PD-L1 Intracellular RNA binding function regulates immune suppression

PROJECT DESCRIPTION/ABSTRACT
Programmed death ligand 1 (PD-L1), which promotes immune escape, is overexpressed in triple negative breast
cancer (TNBC), an aggressive subtype of breast cancer characterized by poor prognosis. Clinically approved
PD-L1 antibodies augment anti-tumor immunity by blocking extracellular PD-1/PD-L1 binding. However, the
contribution of intracellular PD-L1 to anti-tumor immunity and therapeutic resistance has remained poorly
understood. We have discovered a novel role for intracellular PD-L1 as an RNA binding protein that promotes
the stability of target RNAs. This new intracellular PD-L1 function in regulating RNA expression was independent
of the established extracellular role of PD-L1 as the ligand for PD-1. The activity of the anti-tumor immune
response is governed by a balance between immune effector cells and immune suppressor cells. Regulatory T
cells (Tregs) are a CD4+ T cell subpopulation that inhibit effector cell activity, suppress anti-tumor immunity and
promote therapeutic resistance. A hallmark of Tregs is the expression of the transcription factor, Foxp3, which
binds to the promoters of genes that support Treg activity. Foxp1 is a closely related family member of Foxp3.
Emerging data has demonstrated that Foxp1 cooperates with Foxp3 to encourage Foxp3-mediated transcription
and Treg function by maintaining Foxp3 occupancy at promoters of target genes. In our preliminary data, we
have identified Foxp1 as a key PD-L1 target RNA. We have found that the PD-L1 cytoplasmic domain, but not
the PD-L1 extracellular domain, interacts with Foxp1 RNA and promotes Foxp1 expression. In addition, we have
discovered that intracellular PD-L1’s promotion of Foxp1 expression is necessary for proper Treg differentiation,
Treg function, and TNBC progression. The Akt-mammalian target of rapamycin (mTOR) pathway regulates
metabolic reprogramming for proper T cell maturation and function. Our preliminary data suggests that PD-L1
and Foxp1 are required for proper Akt-mTOR pathway activation and metabolism specifically in Tregs, but not
effector T cells, suggesting that targeting the PD-L1-Foxp1 pathway may preferentially inhibit Tregs to address
therapeutic resistance. Our overarching hypothesis is that intracellular PD-L1 stabilizes Foxp1 RNA to
promote Treg immunosuppressive activity and therapeutic resistance. Further, inhibiting intracellular
PD-L1 will promote anti-TNBC immunity by blocking Treg activity. This hypothesis will be tested in a series
of three aims: Aim 1 will determine the influence of intracellular PD-L1 on Foxp1 mRNA stability and Treg
differentiation; Aim 2 will determine the effect of intracellular PD-L1 on Treg function; Aim 3 will compare
intracellular PD-L1 and extracellular PD-L1/PD-1 directed TNBC therapy. Clear delineation of the impact of
intracellular PD-L1 on cancer therapy will provide important insight for optimizing combination strategies aimed
at overcoming immune escape and therapeutic resistance, laying the foundation for the design of the next
generation of TNBC clinical trials.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY We have discovered that a protein called PD-L1, best known for regulating the immune system through interactions outside of cells, also acts inside immune suppressing T regulatory cells to promote their activity. We have found that intracellular PD-L1 suppresses anti-tumor immunity and promotes the progression of triple negative breast cancer, an aggressive subtype which stage for stage has worse prognosis than other subtypes of breast cancer. Our goal in this proposal is two-fold: 1) investigate how intracellular PD-L1 and the PD-L1 cytoplasmic domain influences T regulatory cell development and function and 2) test whether targeting PD-L1 inside of cells (as opposed to outside of cells where clinically available PD-L1 inhibitors act) can promote anti- tumor immunity to improve triple negative breast cancer therapy.